A novel therapeutic strategy to target mutant p53

Project Summary/Abstract
Mutation of the tumor suppressor gene TP53 occurs in more than half of human cancers. Mutant p53
is known to actively drives tumor progression, metastasis, and therapy resistance and thus, is
considered as a promising target for cancer therapy. Our pilot studies showed that RNA-binding
protein Rbm38, upon phosphorylation by CDK4 at serine 195, is able to interact with eIF4G and
subsequently, enhances mutant p53 mRNA translation. We also found that a peptide derived from
Rbm38, called Pep8SD, can bind to a pocket in eIF4G and thereby, disrupt the interaction between
RBM38 and eIF4G, leading to decreased mutant p53 expression and subsequently, growth inhibition.
Moreover, in silico screening identified a small molecule, called 094-63, which bound to the same
pocket as Pep8SD peptide and elicited growth suppression by inhibiting mutant p53 expression.
Furthermore, we found that compound 094-63 was able to attenuate mutant p53 expression in
response to various chemo reagents. Notably, Rbm38, CDK4 and eIF4G are found to be over-
expressed in triple negative breast cancers and associated with mutant p53 expression. Thus, we
hypothesize that targeting the RBM38-eIF4G complex can be explored as a therapeutic strategy for
triple negative breast cancer by specifically suppressing mutant p53 expression. To test this, the
following three aims are proposed: (1) To determine how mutant p53 expression is regulated by the
CDK4/6-RBM38-eIF4G axis and the role of mutant p53 as a target of CDK4/6 inhibitors to suppress
mutant p53-expressing TNBCs; (2) To determine whether disruption of RBM38-eIF4G interaction
suppresses mutant p53 expression and mutant p53-expessing tumors; (3) To determine whether
compound 094-63 blocks DNA damage induction of mutant p53 and sensitizes mutant p53-expressing
tumors to DNA-damaging drugs.

Public health relevance
Project Narrative The proposed study is highly significant and relevant to human health: (1) this study will determine whether a small molecule 094-63 and its analogs, which can inhibit mutant p53 expression by disrupting the Rbm38-eIF4G complex, can be explored as a potential therapeutic agent for tumors addicted to mutant p53; (2) this study will test whether compound 094-63 and its analogs would enhance the efficacy of chemotherapy when combined with chemo-drugs.